Structure and Relations of Protein and Nucleic Acids

Project Summary – Abstract
In this renewal application we describe recent progress in our ongoing studies of DNA-protein interactions,
which have focused largely during the last grant cycle on understanding the molecular mechanisms involved in
the assembly, function and control of the macromolecular complexes that direct DNA replication in bacteriophage
T4, and outline our plans for the next five years. For many years Peter von Hippel served as the sole PI of this
grant, but now this program is a tightly knit joint collaboration between the research groups of Professors Andrew
Marcus and Peter von Hippel at the University of Oregon, who serve jointly as co-PIs of this research project. In
earlier work supported by this grant, the von Hippel lab focused on solution studies of the replication complex of
bacteriophage T4 and the transcription complex of E. coli. We note that these systems involve essentially the
same molecular mechanisms for `driving' and regulating these central life processes as do those of `higher
organisms,' including humans. These studies thus provide good model systems to examine how human DNA
replication proceeds at the functional level, and can help provide insights into what might go wrong in various
genetic diseases, which are often caused by minor quantitative changes in the properties of the `macromolecular
machines' of genome expression.
During the previous reporting period we completed a number of studies on the above mechanistic
questions, using reconstituted DNA replication assemblies that carry out their functions in vitro with essentially
the same rates, fidelities and processivities as do the in vivo versions of these complexes. We proceeded by
placing fluorescent base analogue probes, or cyanine dyes, at defined positions within the DNA frameworks of
the reconstituted complexes, and then used fluorescence and circular dichroism spectroscopy to monitor
biologically relevant conformational changes at and near the probe labeling sites. In this way, we obtained
significant information about replication mechanisms under steady-state or equilibrium conditions, and then
carried forward this work by demonstrating that these same optical probe-labeling strategies can be used in more
complex experiments to permit two-dimensional fluorescence spectroscopy (2DFS), single-molecule Förster
Resonance Energy Transfer (smFRET) and Fluorescence-detected Linear Dichroism (smFLD), which provide
structural interpretations and follow the kinetics of reactions within these complexes in `real time' with µsec to
msec resolution. As described in the present proposal, these approaches now permit us to obtain structural and
dynamic information about local conformational changes that occur at defined and biologically-relevant base
analogue and DNA backbone probe sites, as well as to determine free energy surfaces (and define transition
states) of individual rate-limiting molecular steps within reconstituted models of relatively complete DNA
replication complexes. Using these approaches, we are beginning to reveal mechanisms of regulatory control
systems that have previously been inaccessible to direct experimental measurement.

Public health relevance
Project Narrative Protein-nucleic acid complexes work in living cells to faithfully replicate (copy) the DNA genome to form the genetic material of the daughter cells, to transcribe and process specific messenger RNA sequences to permit `expression' of the defined genes, and to direct the synthesis of specific required proteins at various stages of development. These molecular complexes, which drive and direct these central processes of cellular function, largely self-assemble from individual protein and nucleic acid components to form the so-called `macromolecular machines of gene expression'. We are continuing a program of research that uses the methods of physics and chemistry to understand the specific molecular processes that are involved in the function and regulation of these machines, in part because understanding these central processes in molecular detail will help in the development of specific tools to control diseases of anomalous gene expression and development, including various forms of cancer and related genetic diseases.